Testing Hypothesized Pathways Linking Infection, Physical Activity, Apoe Genotype, And Biological Sex To Low Dementia Prevalence And Reduced Brain Atrophy In Two Native American Populations

The aim of the proposed administrative supplement is to conduct enhanced computerized
tomography (CT) of the brain, mouth/jaw, neck, abdominal aorta, spine, and pelvis by making
use of a newly available CT scanner in Bolivia. The new Canon Aquilion Prime SP CT scanner
was installed in 2023, and this scanner offers both greater resolution and lower radiation
exposure than the original scanner that was previously available. The new scanner will enhance
the study of brain aging (Aim 1 of the parent award) with greater differentiation of grey and white
matter, regional brain volumes, and intracranial calcifications. Supplemental funds are
requested for the increased costs of the enhanced scanning capabilities and to increase
imaging coverage to include the abdomen and pelvis, extending the measurement of
arteriosclerosis to other arterial beds.

Public health relevance
The aim of the proposed administrative supplement is to conduct enhanced computerized tomography (CT) of the brain, mouth/jaw, neck, abdominal aorta, spine, and pelvis by making use of a newly available CT scanner in Bolivia. The new Canon Aquilion Prime SP CT scanner was installed in 2023, and this scanner offers both greater resolution and lower radiation exposure than the original scanner that was previously available. The new scanner will enhance the study of brain aging (Aim 1 of the parent award) with greater differentiation of grey and white matter, regional brain volumes, and intracranial calcifications. Supplemental funds are requested for the increased costs of the enhanced scanning capabilities and to increase imaging coverage to include the abdomen and pelvis, extending the measurement of arteriosclerosis to other arterial beds.